Clin Trl Info Mgt -DCP Enterprise System Knowledge Base (DESK)

To support clinical trials operations. Provide Operations and Maintenance(O & M) support for DESK . Integration with existing or New DCP and /or NCI Systems may be required.